An Ancestry-Informed Approach to Improve Genetic Testing for Cardiovascular Disease

Project Summary/Abstract
Cardiovascular disease (CVD) is the leading cause of death in the United States, making it a promising disease
for genetic testing to predict those at risk and prevent problems before they start. Indeed, genetic testing for CVD
is now being implemented in clinic, however its benefits are not evenly shared and non-European ancestry
individuals are less likely to receive meaningful information from these tests. This is because many genetic tests
are developed using data from European-ancestry individuals, posing a problem when these methods are
applied to a broader population. Further, many tools to study human genomes are geared towards European-
ancestry data and not optimized for diverse genomes. To overcome these challenges and improve genetic
testing for CVD, I propose to study the genetics of CVD across diverse and mixed-ancestry populations using
novel and precise tools that evaluate ancestry appropriately.
Specifically, I aim to improve genetic testing for CVD and lipoprotein a (Lp(a)), a lipoprotein that is resistant to
commonly used CVD medications and can increased someone’s risk for CVD by 2-4X. For Lp(a) in particular, I
will evaluate the role of linkage disequilibrium and genetic structure in the key gene regulating this lipoprotein. I
take this approach as there is poor predictive transferability of currently used genetic tests to Hispanic individuals
that may be explained by different patterns of genetic variation and linkage across ancestries. I will pair these
analyses with phenotypic analyses of Lp(a) and CVD through Genome-Wide Association Studies, and the
development of a novel polygenic scoring model accounting for both a single locus of large effect with polygenic
variation. Doing so will provide me with the critical information needed to improve prevision medicine approaches
for CVD and narrow the disparities that are already being seen in clinic.
To succeed in my goal to improve genetic testing for CVD and Lp(a), I will be developing skills across disciplines
and advocating for the communities most impacted by the disparities that exist in this domain. Through this F31,
I aim to strengthen my knowledge of CVD phenotypes, computational techniques, and science advocacy. The
fellowship will advance my skills to address existing inequities in precision medicine approaches to CVD and
help me further develop my role as an advocate, scientist, and leader in the field of CVD and genetics in the
future.

Public health relevance
Project Narrative Genetic testing for cardiovascular disease (CVD) and elevated lipoprotein a is now being implemented in-clinic to prevent disease and save lives, yet many current tests underperform and are less accurate in non-European populations that are already understudied and underserved. My project aims to fill this gap, doing so through ancestry-informed studies of linkage disequilibrium, GWAS approaches, and a novel method integrating variants of large effect and polygenic variation. Doing so will be an important step to address this existing health inequity and will provide a valuable framework to improve genetic testing for CVD.